TNFR2 sex differences and EAE

Abstract
The susceptibility to Multiple Sclerosis (MS) is believed to be due in part to neuroinflammation
and disease burden linked to neurodegeneration. It is well established that females have a more robust
immune response than males however, neurodegeneration and disease progression are more sever in
males. Thus, in the context of MS, this raises an intriguing question. Do females, by virtue of having a
more robust inflammatory responses, have endogenous protection/repair mechanisms to protect the
central nervous system (CNS) from inflammation induced pathology, that males do not have or that are
not as effective in males? This proposal is based upon extensive preliminary and published data
demonstrating that tmTNF/TNFR2 signaling in females, but not males, significantly improves motor
function and reduces neuropathology in EAE by activating endogenous repair programs in neurons and
oligodendrocytes. Based upon these and other results, our first experimental goal is to interrogate sex
differences in tmTNF/TNFR2 induced improvements in motor function and neuropathology. Further, we
have very novel pharmacological and genetic data that ligation of TNFR2 on both neurons and
oligodendrocytes induce regenerative responses, through IRE1-dependent mechanisms. Based upon
these and additional data our second experimental goal is to investigate the intersection between
TNFR2/IRE1 signaling and to determine if the therapeutic effects of TNFR2 activation are dependent
upon IRE1 activation. These goals will be tested in the following aims:
Specific Aim 1: Investigate the sex-specific effects of tmTNF/TNFR2 signaling in the improvement of
motor function and neuropathology.
A) We will investigate the role of sex hormones in tmTNF/TNFR2 signaling in the improvement of motor
function and neuropathology in male and female mice.
B) We will investigate the role of sex chromosomes in tmTNF/TNFR2 signaling in the improvement of motor
function and neuropathology in male and female mice.
Specific Aim 2: Investigate TNFR2 induced endogenous repair mechanisms in male and female mice.
A) We will interrogate TNFR2 induced endogenous repair mechanisms oligodendrocytes and determine if
they are required for motor recovery in females.
B) We will interrogate TNFR2 induced endogenous repair mechanisms neurons and determine if they are
required for motor recovery in females, in vivo and in vitro.

Public health relevance
Narrative In this application we are investigating the sex bias in EAE and therapeutic potential of a novel TNFR2 agonist and the mechanisms through which it works in significantly reducing neurological burden and supporting remyelination and regeneration in males and females.